Fetal cerebral arteries and prenatal alcohol exposure

In the US, fetal alcohol spectrum disorders (FASD) represent the leading preventable cause of growth delay
and neurodevelopmental retardation in children. Currently, there are no readily available cures against
intended or accidental alcohol exposure during pregnancy and resulting FASD. This lack of therapeutic
countermeasures is largely attributed to the lack of a mechanistic understanding of FASD pathogenesis. While
prenatal alcohol exposure (PAE) targets multiple tissue types and systems, the brain is the most severely
affected organ. Autopsy cases on human fetuses and infants with a history of PAE document abnormal
vascularization of the brain and hypoxic-ischemic neuronal changes or resolving brain hemorrhage. Work on
animal models demonstrates that PAE with maternal blood alcohol levels averaging 80-85 mg/dL dilates fetal
cerebral arteries in vivo independent of changes in systemic circulation, fetal heart function, blood-brain barrier,
blood pH, or pO2. The pathophysiological significance of dilated fetal cerebral arteries is expected to be
profound. First, an alcohol‐unrelated pathology, spontaneous intracranial hypotension, is characterized
clinically by morphological abnormalities of the child’s skull that result from a drop in cerebral blood velocity.
Remarkably, craniofacial malformations serve as the central diagnostic criteria for FASD in humans. Second,
alcohol-induced dilation of fetal cerebral arteries precedes the growth delay of exposed baboon fetuses. Third,
in ovine species, the largest neuronal loss in response to PAE is observed in brain areas that exhibit the
highest cerebrovascular alterations by alcohol. Altogether, clinical and experimental data suggest that changes
in fetal cerebral artery diameter may play a critical role in the pathophysiology of FASD. The extent of the fetal
cerebrovascular component contribution to the pathogenesis of FASD remains to be documented. As we
recently reported, alcohol-induced dilation of fetal baboon cerebral arteries in vitro is fully ablated by a cocktail
of blockers of the endocannabinoid receptors 1 and 2 (CB1 and CB2). The current proposal will utilize a
baboon model to investigate the impact of fetal alcohol exposure by targeting the distinct components of the
eCB system on fetal cerebral artery diameter and fetal growth delay. In sub-aim 1.1, we will use in vitro
pressurized cerebral arteries from fetal baboons, selective pharmacological modulators, and mass
spectrometry of endogenously produced cannabinoids to test the hypothesis that alcohol-induced dilation of
fetal cerebral artery is mediated via distinct components of the eCB system. In sub-aim 1.2, we will use
pharmacological modulators of CB receptors, non-invasive Doppler ultrasonography in vivo, and liquid
chromatography-mass spectrometry proteomics to test the hypothesis that pharmacological blocking of the
eCB system in vivo blunts alcohol-induced dilation of fetal cerebral arteries and diminishes the growth delay of
fetal skull, brain, and vascular tissue. Characterization of the mechanism(s) that govern fetal cerebral artery
responses to alcohol will pave the way for the development of therapeutics against consequences of PAE.

Public health relevance
Fetal alcohol spectrum disorders (FASD) is a leading preventable cause of mental retardation in the United States that develops in children whose mothers engaged into considerable alcohol consumption during pregnancy. Currently, there is no readily available cure for FASD, and the goal of our research is to establish the role of alcohol damage to fetal brain vessels in development of this pathology. If successful, our research will introduce a much needed pathway for therapeutic intervention(s) against FASD.